Research Support Services for the DAIDS

This contract provides research support services that are critical to the research mission of the Division of Acquired Immunodeficiency Syndrome (DAIDS), NIAID. This contract provides the following services: TRAVEL SUPPORT and MEETING AND CONFERENCE SUPPORT, ADMINISTRATIVE AND TECHNICAL SUPPORT.